Injectable reporters to image tumors and guide resection

Project Summary Early detection with clinically translatable molecular imaging agents: Novel clinically translatable molecular imaging contrast agents for detecting tumors by T1-weighted magnetic resonance imaging (MRI) or positron emission tomography (PET) will be developed, optimized, and quantitatively characterized. The MRI agents are activatable cell penetrating peptides (ACPPs) conjugated to dendrimers bearing gadolinium chelates. The ACPPs' selectivity for matrix metalloproteinases and the stability of the gadolinium chelates will be optimized. The PET reporters will be reduced-size antibodies bearing novel near-infrared (NIR) fluorophores incorporating 18F-fluoborates. Both MRI and PET agents will be tested in mice on tumors stably expressing genetic reporters for fluorescence (FL), bioluminescence (BL), and positron emission tomography (PET), combining best available versions of far-red fluorescent protein, firefly luciferase, and thymidine kinase, expressed as separate but genetically linked proteins separated by self-cleaving viral 2A sequences. These tests will quantify how reliably can such injectable agents detect solid tumors of different sizes and stages of progression, under what circumstances false positive and negative signals are obtained, when is either combination of probe and imaging modality superior to the other, and whether indolent vs. highly malignant and invasive tumors can be distinguished. Evaluation and improvement of FL-guided surgical resection and adjuvant therapies: Intraoperative FL guidance from injectable agents such as ACPPs conjugated to fluorescent dendrimers, reduced-size antibodies labeled with NIR fluorophores, or 5-aminolevulinate will be compared with FL guidance from the fluorescent protein representing perfect tumor-specific labeling. These comparisons will show which injectable agent performs best under what circumstances, and whether completeness of fluorescence-guided resection is limited more by imperfect biochemical specificity of current contrast agents, or by inability to resolve and manually remove scattered or disseminated tumor cells. Photodynamic therapy (PDT) to kill off residual tumor cells in the surgical field before closure will also be tested. Completeness of initial tumor removal and any recurrence will be assessed postoperatively using the genetic reporters. Comparison with signals from injectable contrast agents and traditional survival measures should quantify how surgical outcomes depend on the thoroughness of tumor cell removal, how much improvement results from current injectable contrast agents vs. genetically perfectly labeling, whether PDT helps, how well can current injectable agents monitor recurrence, and what materials or procedures most need improvement.

Public health relevance
Project Narrative This project aims to develop, optimize, and characterize the performance of novel injectable, clinically translatable contrast agents for early detection of tumors, distinction between indolent and aggressive cancers, molecular fluorescence-guided surgery, and postoperative monitoring. The long-term goal is to improve detection of aggressive tumors while they are still small and localized, and to help surgeons remove those tumors accurately completely while sparing as much normal tissue as possible. __SpecificAimsTextDelimiter__ SPECIFIC AIMS 1. Early detection with clinically translatable molecular imaging agents: An urgent challenge in molecular imaging is to devise whole-body scanning techniques that can reliably detect a wide range of tumor types early in their development, ideally before the tumors have become large enough (roughly 1 mm diameter) to require new blood vessels. At this stage, tumors are most likely to be completely curable by resection. Even if this challenging goal cannot be achieved immediately, improvements over current techniques requiring centimeter-sized tumors would still be highly desirable. We propose to optimize and test in mouse models two new types of clinically translatable molecular imaging contrast agents aimed at these goals. a) Activatable cell penetrating peptides (ACPPs) undergo cleavage by tumor-associated proteases such as matrix metalloproteinases (MMPs) and thereby become locally converted to highly adhesive "cell penetrating peptides". ACPPs conjugated to dendrimers bearing gadolinium chelates make tumors visible by T1-weighted magnetic resonance imaging (MRI). The dendrimers may also contain far-red or near-infrared fluorophores to enable post-MRI histological localization or intraoperative guidance by fluorescence (FL). Combining both MRI and FL into the same nanoparticle ensures intermodality comparability and minimizes the number of separate molecular entities eventually requiring regulatory approval. We wish to test several promising improvements on such ACPP-dendrimers, including pretargeting of ACPPs to MMP-2 via the latter's known association with αvβ3 integrin, substrates with selectivity for intrinsically membrane-anchored MMPs, and improved Gd chelates. MRI performance of ACPP-dendrimers, both existing and hopefully improved versions, will be evaluated on a broad range of tumor types as quantitatively as possible, e.g. by estimating receiver operating characteristics as a function of the size of tumors as they grow. To enable nondestructive reference measurements of tumor size and cell number using bioluminescence (BL) and fluorescence (FL), the tumor cells are clones already selected for stable high level expression of luciferase and an optimal red fluorescent protein, E2-Crimson. ROC analyses will be valuable to assess progress towards reliable detection of ~1 mm3 tumors and to decide which variations in nanoparticle preparation give performance improvements. b) Reduced size antibody fragments called cys-diabodies optimize the balance between high divalent avidity for targets, diffusibility into solid tumors, and rapid clearance from normal organs. Cys-diabodies will be labeled with novel near-infrared fluorophores that rapidly incorporate aqueous 18F under very mild conditions to form stable fluoborates. Such conjugates are detectable in whole animals by positron emission tomography (PET) and subsequently visible by FL for intraoperative guidance or higher spatial resolution histology. PET imaging performance of different cys-diabody conjugates on various tumor types will be quantified analogously to the MRI contrast agents to enable balanced comparison. c) A related major clinical need is for imaging techniques that can distinguish between indolent and aggressive tumors. Literature suggests that aggressive tumors tend to have higher levels of relevant MMPs, and we have paired cell lines illustrating this correlation. We will test whether indolent vs. aggressive tumors of the same size can be distinguished by MRI of ACPP-dendrimers. 2. Evaluation and improvement of FL-guided surgical resection and adjuvant therapies: With the growing interest in molecularly-targeted FL to guide surgery, we need to know whether success in complete resection is limited by the molecular specificity and tumor/normal ratio of current contrast agents, or by more fundamental limitations such as the difficulty of visually detecting and manually excising low abundance tumor cells dispersed from the primary tumor bed. Therefore we will implant cells marked with BL, FL, and PET genetic reporters, wait for them to become tumors of varying sizes and extents of local invasion, then compare intraoperative FL guidance from injectable agents including ACPPs conjugated to fluorescent dendrimers, cys- diabodies with near-IR fluorophores, and 5-aminolevulinate, vs. FL guidance from the fluorescent protein representing perfect tumor-specific labeling, vs. traditional white-light reflectance only. We also wish to confirm and extend promising preliminary evidence that ACPP-targeted photodynamic therapy (PDT) can kill off residual tumor cells in the surgical field before closure. Completeness of initial tumor removal and any recurrence will be assessed postoperatively primarily using BL, possibly supplemented by FL or PET of the genetic reporters within the cells. These gold standards will be compared with postoperative MRI and PET using the injectable contrast agents to show how well can the clinically translatable probes monitor the response to surgery. Comparison of all these forms of imaging with traditional survival measures should quantify how surgical outcomes depend on the thoroughness of tumor cell removal, how much improvement results from our injectable contrast agents vs. genetically perfectly labeling, whether PDT helps, how well can the injectable agents monitor recurrence, and what materials or procedures most need improvement. Projected timelines: Years 1-3: optimizing ACPP cleavage & testing existing ACPP-dendrimers for MRI early detection, FL-guided surgery, and PDT. Years 2-3: testing cys-diabodies for PET early detection and FL-guided surgery. Years 4-5: optimizing most promising probes and procedures, selecting top candidates for eventual clinical development.